Mechanisms underlying aged host-virus interactions

PROJECT SUMMARY
The elderly proportion of the human population is increasing rapidly on a global scale leading to unprecedented
demographic shift impacting families, governments and health care systems. In addition to being at higher risk
for developing chronic disease, older individuals are more vulnerable than younger adults to infectious diseases,
including viral infections, and often exhibit higher incidence, severity and mortality rates. Moreover, the aged
organism represents a favorable environment for the accumulation of mutations in viral genomes that could
possibly result in the emergence of novel pathogenic strains of significant public health concern. The exact
mechanisms leading to that, however, are not known. Despite numerous advances in understanding virus-host
interactions, we do not know if differential processes underlie these relationships as a function of age. With ever-
increasing numbers of older persons on the planet, appropriate preventive and treatment strategies leading to a
longer, healthier life are becoming increasingly urgent. Consequently, there is great need to unravel the
fundamental mechanisms that allow the aged organism to survive infection and limit pathogen spread.
Here, we propose to use the model organism Drosophila melanogaster to identify the mechanisms that
contribute to age-dependent survival of infection with the RNA Flock House Virus (FHV) and the influence of the
aged organism on viral pathogenicity. The host and the virus reciprocally affect each other and we will examine
both how the aged host responds to, and conversely affects, the virus. We propose to use an innovative
combination of genetic, molecular, metabolic and next generation sequencing methods to: (1) determine how
modulation of host’s metabolism in older individuals aids in survival of viral infection and (2) determine how the
aged organism’s physiological milieu impacts the evolution of RNA virus pathogenicity. Our experiments will
focus on investigating the role of infection tolerance mechanisms that rely on the modulation of organismal
metabolism as an age-dependent strategy to survive infection. To determine how the aged host’s physiological
environment potentiates RNA virus pathogenicity, we will examine the architecture of viral genomes, including
the build up of defective viral species, following replication in older versus younger individuals, and over several
passages in vivo. We will also test the contribution of increased oxidative stress in this process using both genetic
and pharmacological approaches, and perform pathogenicity studies using identified candidate viral variants.
The underlying genetic and molecular mechanisms are likely to be conserved from flies to humans and our
studies will provide important new insights filling the knowledge gap about the interactions of viruses and aged
hosts in general. Our studies could potentially lead to therapeutic improvements for infected elderly patients as
well as to the prevention of the emergence of novel viral strains.

Public health relevance
PROJECT NARRATIVE Our research goals are to understand why older individuals exhibit higher severity of and mortality from viral infections than younger adults and how viruses evolve within their aged hosts. Our studies in the fruit fly Drosophila show that we can effectively model aged host-virus interactions in this genetically tractable organism and we are using this system to identify the cellular and molecular mechanisms that underlie the capability of the aged organism to survive infection and limit pathogen mutations and spread. This research could potentially lead to therapeutic improvements for infected elderly patients as well as to the prevention of the emergence of novel viral strains.